Arthritis questions on the 2023 National Health Interview Survey

The purpose of this agreement is for the National Institute of Arthritis and
Musculoskeletal and Skin Diseases (NIAMS) to provide financial support to the National
Center for Health Statistics (NCHS) to add questions about arthritis to the National
Health Interview Survey. This project is a collaborative effort between NCHS, NIAMS,
and NCCDPHP/DPH.